Data, Biostatistics & Modeling Core

The Data, Biostatistics & Modelling Core will act as a repository for data collected during the field-based
projects, enabling efficient linking of epidemiological, molecular, immunological and other biological data
measured from the participants.
Mathematical models will play an integral role: analysing collected data to generate hypotheses which will be
verified or falsified against subsequently collected data. In Project 1: Epidemiology, data collected during the
initial cross-sectional surveys in Papau New Guinea, Thailand and Cambodia will be used to inform the design
of various surveillance strategies. The potential effectiveness of these strategies as interventions to reduce
malaria transmission will be simulated using data driven mathematical models of P. vivax and P. falciparum
transmission. The most promising strategies will then be taken forward for testing in field trials.
Mathematical models will also make an important contribution to Project 3: Relapse. Samples collected during
longitudinal studies will be genotyped to provide a detailed understanding of the dynamics of P. vivax and P.
falciparum infection. The combination of epidemiological data and genotyping methods will not allow for
definitive classification of P. vivax infections into relapses, re-infections, or recrudescences. Instead, this
classification will be done probabilistically using a specially designed within-host mathematical model. This
model will generate probabilistic phenotypes which can be compared to a wide range of potential genotypic
markers.